CORE 2: Technology Core

TECHNOLOGY CORE
SUMMARY
Systematic characterization of protein and genetic interaction networks of respiratory pathogens in disease-
relevant cells and 3D culture is critical for the identification of functional host-pathogen complexes and targets
for therapeutic development. Systems biology approaches that determine protein-protein interactions
(PPIs), characterize protein and posttranslational modification (PTM) abundance changes during infection, and
classify functional host factors that regulate infectious disease pathogenesis, can provide strategic insight and
generate models of respiratory pathogen infection. Combined with visualization of key host-pathogen
complexes at atomic level through structural biology, and integrating with clinical and patient data related
to disease severity, our innovative “systems to mechanism, bedside to benchtop” approach can be
incredibly powerful for the identification of new therapeutic targets and for predicting respiratory disease
outcome. The Technology Core will provide the infrastructure and technological expertise essential to
the completion of the overall Host Pathogen Map Initiative (HPMI) 2.0 objectives. With support of Core
facilities, the Technology Core will provide a suite of state-of-the-art proteomic technologies (Thermo
Fisher Scientific Proteomics Facility for Disease Target Discovery, UCSF, Quantitative Biosciences
Institute (QBI), Gladstone Institute), genetic screens (Innovative Genomics Institute, UCBerkeley),
and structural biology approaches (UCSF Advanced Microscopy Laboratory and Crystallography
Facilities, UCSF) for the generation of high-quality data, which will be integrated in collaboration with the
Data Management and Bioinformatics and Modeling Core with clinical and patient derived data. Our
goal is to provide PPI and global proteomic analyses, genome-wide and targeted knockdown and
knockout genetic screens, and structural characterization of host-pathogen interactions for Mycobacterium
tuberculosis (Mtb) (Project 1), and respiratory viruses: SARS-CoV-2, IAV, IBV, RSV, and HPIV (Project 2).
We will analyze selected variants and clinical isolates for each pathogen in disease-relevant cell lines,
primary cells isolated from healthy donors or mice, 3D-culture models including human airway epithelial
organoids, and infected patient samples. Finally, we will continue to develop, optimize, and innovate new
technological advances as needed to support Project 1 and 2 and HPMI 2.0 overall goals.